Liquid biopsy for alcoholic hepatitis: diagnosis, prognosis and technology development

PROJECT SUMMARY/ABSTRACT
The long-term objective of this translational U01 is to define pathophysiologically informed and clinically
relevant biomarkers based on the sphingolipidomic cargo of extracellular vesicles (EVs) that will serve for the
diagnosis and prognosis of subjects with alcoholic hepatitis (AH). AH is the severest form of alcohol-induced
liver disease with high mortality, high health care utilization, and the absence of effective therapies. Health care
professionals are limited by the lack of predictive and prognostic biomarkers that could risk-stratify AH patients
and individualize their therapy based on biomarker profiles. The current proposal links hepatocyte-derived
sphinogolipid cargo on EVs to macrophage-mediated liver inflammation by proposing that sphingolipids on EVs
from ethanol-damaged hepatocytes recruit macrophages in to the liver, resulting in liver injury and
inflammation. Our preliminary data show that EVs are elevated in AH with the following features: i) EV
sphingolipids are elevated in AH; ii) EV sphingolipid levels correlate with clinical parameters such as the
international normalized ratio, bilirubin, and MELD score; iii) EVs activate proinflammatory macrophage
effector responses via sphingolipid signaling; and iv) Hepatocyte-derived EVs can be detected via a novel
nanoplasmon enhanced scattering (nPES) assay. This has led to the central hypothesis that circulating EV
sphingolipid cargo is a pathogenically relevant biomarker for the diagnosis and prognosis of AH.
Therefore, the goals of this proposal are to: i) develop an EV sphingolipidomic diagnostic signature for AH; ii)
Demonstrate the ability of EV sphingolipidomics to predict mortality in AH; iii) Extend EV sphingolipidomics to a
“proof-of-mechanism” assay for the beneficial effects observed in AH patients treated with therapeutic agents
proposed in our linked complementary Clinical Trial Pilot U01 (RFA-AA-18-005); and iv) Develop a novel
clinical test for the diagnosis of AH utilizing nPES technology to diagnose AH by detecting hepatocyte-derived
EVs in plasma microsamples. First, we will determine the diagnostic performance of EV sphingolipids for AH in
a single-site training cohort followed by a multi-site validation cohort. Second, we will directly test the
hypothesis that EV sphingolipids can predict survival and response to a therapy that is expected to reduce the
release of EVs from hepatocytes. Third, we will develop and validate a novel clinical assay for the diagnosis of
AH. Thus, this multi-PI U01 grant application will yield a liquid biopsy biomarker for AH diagnosis and
prognosis.

Public health relevance
PROJECT NARRATIVE Alcoholic hepatitis is a severe illness with high mortality and no effective therapies due in part to the lack of tests that permit early diagnosis. We propose to develop a novel blood test based on the detection of liver- derived extracellular vesicles for the early and rapid diagnosis of alcoholic hepatitis, and we will also test whether these extracellular vesicles can predict which patients are most likely to die from this condition. Therefore, with the proposed studies we hope to identify, characterize, and validate that extracellular vesicles can serve as a clinically relevant biomarker for alcoholic hepatitis which can risk-stratify patients and uncover potentially targetable pathways for treatment.